Center on Aging and Population Sciences

Overall: Abstract
The University of Texas at Austin requests P30 funding to establish a new Center on the Demography and
Economics of Aging—The Center on Aging and Population Sciences (CAPS). The new Center’s
overarching mission is to galvanize novel research that illuminates how biosocial and environmental factors
intersect, compound, and cascade throughout the life course to shape health and well-being at older ages.
CAPS will provide specialized programming and leadership to foster innovative demographic and population-
based research on aging. The Center will leverage substantial faculty strengths and new institutional
commitments to greatly amplify the impact of NIA P30 support. CAPS will share administrative resources with
the highly successful Population Research Center (PRC) at UT Austin. The extensive experience and expertise
of PRC administrators and staff will multiply the impact of CAPS activities to promote exceptional population-based
research on aging. The Center’s specific aims are: 1) Expand and promote collaborations among scholars to
address complex aging and population health issues, create a lively and supportive interdisciplinary community
wherein exchange of ideas is encouraged and common, and grow the number and diversity of researchers in
the field at all career stages, 2) Promote and sustain infrastructure development needed to provide high-quality
services and resources to foster outstanding population-based research on aging, and 3) Oversee a project
development and pilot program to seed new lines of population-based research on aging.
Over the next 5 years, CAPS will address critical research questions regarding dynamic and intersecting
factors throughout the life course that shape diversity in aging and health within three overarching research
themes: 1) Life course precursors of advantage and disadvantage at older ages, 2) Family demography, social
engagement, and social isolation, and 3) Place, aging, and health. Funding is requested for two infrastructure
cores. The Administrative and Research Suppoert Core will set programmatic and service priorities; build an
interdisciplinary community of population scientists at the University; provide outstanding services that facilitate
the development of large-scale population research; ensure coordination between cores, and serve as the
communications hub between CAPS, NIA, and the Coordinating Center. The Program Development and Pilot
Core will generate novel scientific projects of well-established scientists as well as early-stage and new-to-
aging scholars to significantly advance population-based research on aging; build CAPS research portfolio via
the Center’s pilot project program, and foster evolution of nascent ideas into proposals for extramural funding.
CAPS will prioritize pilot projects that are most likely to advance knowledge, address NIA priorities, shift
conceptual paradigms, develop novel sources of data, and lead to major NIA funding within CAPS themes.

Public health relevance
Project Narrative This application proposes to establish a new NIA P30 Center on the Demography and Economics of Aging at The University of Texas at Austin (UT Austin)—The Center on Aging and Population Sciences (CAPS). CAPS will promote and support research key to the mission of the NIA P30 program, particularly novel research that illuminates how biosocial and environmental factors intersect, compound, and cascade throughout the life course to shape health and well-being at older ages. CAPS research will offer new insights critical to furthering the health and well-being of a diverse aging US population.